Innovations for peer-delivered and family-engaged brief interventions for youth suicide in Nepal: A pilot hybrid type 2 implementation study

Program Summary
Our proposal aims to co-design and pilot trial the implementation of a package of brief
interventions for suicide prevention among youth (12-24 years of age) delivered by Peers (YPF-
SuPP). YPF-SuPP will contain two evidenced-based interventions tested in South Asia (safety
planning and contact follow up) with two core innovations: safety plans delivered through a
personalized youth-designed jewelry and protocolized strategies to culturally and safely engage
trusted family members to support youth. We will leverage a nationally renowned non-
governmental organization (Social Changemakers and Innovators – SOCHAI) in Nepal and their
well-supported Peer Volunteer workforce to deliver YPF-SuPP alongside the existing health
system. We establish an implementation system that provides supportive supervision to Peers.
Using equity-informed and participatory mixed methods we will establish two advisory boards, a
Youth Advisory Board and a Community Advisory Board of local adolescent mental health
clinicians, suicide experts, teachers, family members of youth with lived experience of suicide,
and youth advocates. We focus our work on a marginalized municipality of Makwanpur District,
focusing on providing care to care for minority ethnicities (Tamang and Chepang) in Nepal. We
will identify successes and improvement based on operationalized benchmarks to move on to a
fully powered hybrid type 2 clinical trial. Youth clinical outcomes include suicide-related coping,
suicide ideation severity, and mental health service use, among other secondary and mechanistic
domains. Implementation outcomes include reach, adoption, acceptability, appropriateness,
fidelity, and potential for sustainment.
This
intervention
at
study wil l lay the groundwork for a future cluster randomized trial of the YPF-SuPP
to evaluate its effectiveness in delivering robust, community level, support for youth
risk for suicide.

Public health relevance
PROJECT NARRATIVE South Asia has the highest suicide rate in the world with important risk profile differences from high-income settings. We will conduct formative research to co-design a package of brief interventions and implementation strategies to prevent youth-suicide and then test the package in a pilot feasibility hybrid type 2 cluster randomized controlled trial in Nepal. Potential health impacts may be substantial as results can be applied not only in similar South Asian primary healthcare contexts, but also in low-resource settings in the US and abroad, where the suicide burden remains high.